Animal and Microsurgery Core (Core B)

Project Summary/Abstract
The purpose of the Animal and Microsurgery Core (Core B) is to establish a focused facility that provides
investigators in each of the two projects with sufficient breeding of animals with specified genotypes, and with
standardized cardiac or skin transplantation and tolerance induction procedures for the proposed experiments.
Core B will provide a key service role that will enable the Principal Investigators and their staff to focus on
experimental and scientific efforts. Centralized breeding and screening of the progeny will ensure that animals
of required genotypes are available for the proposed experiments. Transplantation performed by a centralized
source will standardize the procedures, minimize surgically imposed disparities in the grafts used by the two
projects and allow some long-term acceptors generated for Project 1 (addressing vulnerabilities to the
maintenance of transplantation tolerance) to be used for Project 2 (confronting the barrier to stable
transplantation tolerance posed by memory T cells) to minimize experimental costs. In addition, the purchase of
supplies, such as sutures, anesthetics and immunosuppressants will be done in bulk for both projects to reduce
cost. The specific tasks of Core B will be to: a) breed and genotype animals to be used for both projects; b)
transplant heart allografts as directed by the project leaders and their personnel; c) prepare and inject donor
splenocytes and administer indicated immunosuppressive therapies; d) monitor the beating of the transplanted
hearts, the health of the transplant recipients, and record times of rejection; e) sacrifice transplanted animals as
directed by the Principal Investigators and their personnel, and collect organs for histology, as well as to distribute
to other project personnel for phenotypic and functional analyses of immune cells.

Public health relevance
Transplantation tolerance, a state of immune hyporesponsiveness to a graft following cessation of immunosuppressive therapy, can prevent complications from life-long global immunosuppression but is rarely attained in the clinic. This PPG addresses the barriers to both the induction and long-term maintenance of transplantation tolerance, and explores two potential solutions that leverages the natural ability of pregnancy to tolerize fetus-reactive T cells and harnesses the capacity of chronic antigen exposure to drive immune hypofunction.